Anxiety in Parkinson’s disease: using fMRI to evaluate amygdala networks in the on and off dopamine state

PROJECT SUMMARY
Anxiety is a top unmet need in people with Parkinson's disease (PD) associated with high levels of
distress, caregiver burden, lower quality of life, and disruption of usual activities. Diagnosis and treatment of
anxiety in PD is complicated due to its association with dopamine fluctuations, comorbidity with depression, and
lack of evidence-based treatments. The result is that anxiety often goes undiagnosed and untreated, or is treated
with inappropriate, potentially dangerous medications. The goal of the proposed study is to understand the brain
networks involved in anxiety, test how they are affected by dopamine fluctuations resulting from the treatment of
PD motor symptoms with dopaminergic agents, and determine if anxiety and depression have dissociable neural
networks in PD.
The study aims to achieve these goals using detailed psychiatric and neuropsychological assessments
as well as high-resolution functional magnetic resonance imaging (fMRI) methods in PD patients with anxiety,
PD patients without anxiety or other psychiatric conditions, and healthy controls. A targeted fMRI activation task
will be employed designed to tax medial temporal lobe networks including the amygdala. High-resolution resting-
state fMRI will be used to assess connectivity between amygdala and local and whole brain cortical networks.
Completing these assessments both during the on and off-dopamine medication state will further help determine
whether anxiety and underlying amygdala networks are altered by fluctuations in dopamine levels.
Together the proposed studies will provide key insights into the role of the amygdala, its subregions, and
its networks in the experience of anxiety in PD. The results will determine whether anxiety and depression are
dissociable conditions in PD subserved by distinct amygdala subregions and networks in PD. Finally, this work
could additionally provide a target for the development of new therapeutic interventions for anxiety in PD.

Public health relevance
Narrative Anxiety co-occurs with depression often complicating both diagnosis and treatment leaving anxiety a top unmet need in patients with Parkinson's disease (PD). Using detailed behavioral testing and high-resolution brain imaging methods, this project aims to better understand the brain networks that cause anxiety and determine if they are different from the brain regions involved in depression. The proposed study also aims to shed light on the relationship between anxiety and changes in dopamine levels caused by PD medications by performing functional MRI in both the on- and off- dopamine medication state in PD patients with anxiety compared to PD without anxiety, and healthy controls.